Distinct mechanisms for memory storage and retrieval in hippocampal engram cells

Abstract Neurobiological mechanisms underlying learning and memory have been extensively studied in animals. However, very little is known about the cellular processes that support retrieval. This may be the case because retrieval is often assumed to be a direct function of memory strength. The more learning that took place, the easier retrieval should be. However, research on human memory has demonstrated that storage strength and retrieval strength are dissociable processes. The former is long-lasting and influenced by the amount of training while the latter fluctuates and depends on temporal factors like how long ago the memory was encoded and retrieved. These unique properties suggest that storage strength and retrieval strength are regulated by distinct cellular mechanisms. Consistent with this idea, norepinephrine (NE) release is required for memory retrieval in the hippocampus but is not necessary for learning. Conversely, dopamine (DA) release is essential for learning but is not required for memory retrieval. Given that much is already known about DA and the role it plays in learning, the current application will characterize the relationship between NE release, intrinsic excitability and memory retrieval. In doing so, we will test the hypotheses that: 1) Phasic release of NE during testing enhances memory retrieval and prevents forgetting 2) Phasic release of NE increases the intrinsic excitability of engram cells and facilitates their reactivation during testing.

Public health relevance
Project Narrative A number of human disorders affect the hippocampus and impair long-term memory. Consequently, a major goal of the NIH is to understand the basic mechanisms by which this structure stores and retrieves information. Our proposal will test the idea that norepinephrine release increases the intrinsic excitability of hippocampal neurons and facilitates memory retrieval. This research is clinically significant because changes in intrinsic plasticity are recognized as prominent, pathological features of many CNS disorders. Changes in catecholamine function also accompany many human disorders like Alzheimer’s disease, Parkinson’s disease, schizophrenia, bipolar disorder, ADHD and PTSD. Characterizing the mechanisms by which norepinephrine release and intrinsic excitability regulate memory in the hippocampus could lead to new insights and treatments for these disorders.